Harnessing the human monocyte system to improve surgical recovery

Harnessing the human monocyte system to improve surgical recovery
Over 30 million patients undergo a major surgery annually in the US. Patients’ recovery after surgery is highly
variable and can be severely compromised by complications, such as infections, prolonged pain, and functional
impairment. However, our current approaches to predict a patient’s recovery are anchored in clinical and
phenotypical data and perform poorly. Surgical injury produces a multi-cellular immune response that, when
dysregulated, leads to adverse surgical outcomes. Examining the human immune system in depth, in patients
undergoing surgery is a logical and promising strategy to identify biological signatures for risk prediction and to
reveal mechanisms that can be exploited to improve surgical recovery.
Our research program utilizes the high-dimensional immune monitoring of patients undergoing surgery to identify
modifiable immunological mechanisms that accurately predict a patient’s recovery. This MIRA proposal builds
on our extensive translational research indicating that immune responses contained in the human Monocyte
System (hMS) strongly correlate with pain resolution and functional recovery after major joint replacement
surgery. We will pursue three inter-related, but non-overlapping goals focusing on the hMS: First, we will assess
the phenotypic and functional dynamics of circulating monocytes in response to surgery to determine the role of
the hMS in the pathobiology of surgical recovery. Second, we will interrogate the hMS before surgery to
determine whether patients’ pre-surgical immune states determine the course of surgical recovery. Third, we will
use a reverse translational strategy using a pre-clinical mouse model of surgery to test whether “druggable”
immunological targets identified in humans can accelerate recovery. We will use the following innovative and
multidisciplinary strategies: 1) high-dimensional profiling of the hMS in response to surgery using single-cell
mass cytometry (including dynamic alterations in cell phenotype, homing properties and effector responses); 2)
identification of cellular, epigenetic and proteomic elements of a patient’s hMS, using an integrative analytical
pipeline developed by our group; 3) evaluation of new targets for selective modulation of monocyte signaling
responses in a mouse model that recapitulates hallmarks of the human immune response to surgery.
A major strength of this proposal is the study of trauma-related immunology in a pertinent patient population by
a clinician-scientist who has effectively pioneered high-content immune monitoring techniques at the bedside.
The current program focuses on pain and functional impairment after orthopedic surgery. However, we will study
fundamental mechanisms that are likely shared across many acute inflammatory conditions (e.g. other surgeries,
blunt trauma or traumatic brain injuries). As such, we will be able to pivot towards the integration of our findings
within the broader immunologic, metabolic, and neuro-hormonal responses to injury and the evaluation of other
adverse outcomes after traumatic injury, such as infections, sepsis, or neuro-cognitive impairment.

Public health relevance
NARRATIVE Over 30 million major surgeries are performed annually in the US alone. Delayed surgical recovery marked by persistent pain and prolonged functional impairment causes personal suffering, longer exposure to opioids, and decreased quality of life, contributing $8 billion annually to US health care costs. However, biological markers that allow us to accurately predict surgical recovery in individual patients are lacking. My research program will examine the human monocyte system in patients undergoing surgery to identify immunological mechanisms that predict a patient's recovery after surgery and point at modifiable targets for the development of immune- modulating interventions that will safely accelerate surgical recovery.